The Role of MicroRNA in Osteoarthritis

Abstract
Significant progress has been made in recent years in osteoarthritis (OA) research, including the generation of
mouse models, including genetic and surgically-induced OA mouse models that show an OA-like phenotype.
One feature that is common to these mouse models of OA is the up-regulation of Runx2. Because Runx2 is a
key transcription factor directly regulating the expression of genes encoding for matrix degradation enzymes,
such as Mmp9, Mmp13 and Adamts5, this up-regulation leads to the increase in expression of these genes.
The key questions have been raised. 1) Is Runx2 a central molecule mediating OA development in joint tissue?
2) Could manipulation of Runx2 expression be used to treat OA disease? miRNAs are endogenous non-
coding RNAs and play important roles in regulation of RNA stability and protein expression. Previous studies
by our lab have shown that miR-204/-211, two homologous miRNAs, bind Runx2 and regulate Runx2
expression in mesenchymal stem cells (MSCs). To determine the function of these miRNAs in Runx2
regulation and in OA development, we have recently created miR-204 and miR-211 floxed alleles and further
generated miR-204/-211 double KO mice (dmiRPrx1 and dmiRAgc1ER) by breeding miR-204flox/flox and miR-
211flox/flox mice with Prx1-Cre (targeting limb MSCs) or Agc1-CreER (targeting adult articular chondrocytes)
transgenic mice to delete these miRNAs. A severe OA-like phenotype was observed in dmiRPrx1 and
dmiRAgc1ER KO mice and entire knee joint tissues were affected by miR-204/-211 deletion, including severe loss
of articular cartilage, subchondral sclerosis, chondrophyte/osteophyte formation, and synovial hyperplasia.
Our findings suggest that miR-204 and miR-211 are key regulators in maintaining joint tissue homeostasis and
could be served as critical targets for OA treatment. The underlying hypothesis of this project is that miR-
204 and miR-211 are key regulators of Runx2 expression and play critical roles in maintaining joint tissue
homeostasis. Two specific aims have been proposed to test this hypothesis. In Aim 1, we will fully
characterize the longitudinal effects of miR-204/-211 deletion on OA development in dmiRAgc1ER KO mice and
determine if deletion of Runx2 in chondrocytes will reverse OA phenotype observed in dmiRAgc1ER KO mice. In
Aim 2, we will investigate changes in miR-204/-211 expression in OA samples and determine if in vivo
administration of miR-204 will prevent OA development or decelerate OA progression in surgically-induced OA
mouse model. These proposed studies will provide novel insights into mechanisms of OA development and
will help the development of new strategies for OA treatment.

Public health relevance
Project Narrative Osteoarthritis (OA) is the most common form of arthritis and is the leading cause of impaired mobility in the elderly. More than 67 million people have been forecasted to be affected by OA in the US by 2030, resulting in an extremely high socio-economic burden. Significant progress has been made in recent years in OA research and different OA mouse models have been generated. One feature that is common to these mouse models of OA is the up-regulation of Runx2, a key transcription factor, leading to further increase in genes encoding for matrix degradation enzymes. The key questions have been raised. 1) Is Runx2 a central molecule mediating OA development in joint tissue? 2) Could manipulation of Runx2 expression be used to treat OA disease? We have recently shown that mice with deletion of two homologous miRNAs, miR-204/-211, develop a severe OA phenotype. We hypothesize that miR-204/-211 are key regulators in Runx2 expression and play critical roles in maintaining joint tissue homeostasis. In the proposed studies, we will determine the molecular mechanism of gene regulation by miR-204/-211 in joint tissue and determine if the administration of miR-204 into joint tissues will inhibit OA development in a surgically-induced OA mouse model. Our proposed studies will contribute to the development of new strategies for OA treatment.